AI-guided miniproteins driving the production and functional endurance of pancreatic islet tissue from pluripotent stem cells.

Summary
Stem cell (SC)-based replacement therapy is emerging as promising cure for diabetes.
However, population-wide applicability of this approach remains constrained by the limited
efficiency of current protocols in controlling the state of pluripotency and/or patient-specific
propensity of SC lines to respond to morphogens and inductive factors, thereby yielding
heterogenous islet cell preparations containing variable proportions of endocrine and immature
cell types.
In this RC2 project we integrate knowledge from a team of Investigators with a complementary
expertise to exploit the power of Artificial Intelligence (AI)-designed mini-proteins (EpiBinders) in
controlling SC ability to more efficiently differentiate into functional islet cells. This approach is
based on our recent work demonstrating that EpiBinders are capable of erasing repressive
histone methylation marks and activate select genes of interest, thus fostering the activation of
downstream developmental programs. Building on this preliminary work, our hypothesis is that
the newly discovered regulatory function of AI-designed EpiBinders on gene expression can be
harnessed to drive a more efficient differentiation of multiple SC lines into functional islet tissue.
Hence our collaborative project will focus on the following specific aims: Aim 1. Develop and in-
cell validate a toolbox of Al-designed mini-proteins targeting epigenetic regulators of islet cell
development and function beyond PRC2 inhibitor in multiple iPSC lines. Aim 2. Apply and validate
the toolbox of EpiBinders for the regulation of islet cell development and function at specific stages
of SC differentiation. Aim 3. Characterize states of differentiation, functional maturation and
metabolic endurance of epigenetically manipulated SC-derived islet cells, in vitro and in vivo in
transplantation models.
We anticipate that our interdisciplinary efforts will produce new knowledge and resources that
will be readily shared with the scientific community, and that will advance collective efforts to
broaden the future therapeutic potential of SC-based treatments by developing a radically new
approach to enhance efficiency of islet tissue derivation from SC.

Public health relevance
Narrative Stem cell (SC)-based replacement therapy is emerging as promising cure for diabetes, but the population-wide applicability of this approach remains constrained by the limited efficiency of current protocols of differentiation to produce homogeneous preparations of functionally mature islet tissue. In this collaborative project we integrate knowledge from a team of Investigators with complementary expertise to exploit the power of AI-designed mini-proteins in driving a more efficient differentiation of multiple SC lines into functional islet tissue. We anticipate that our interdisciplinary efforts will produce new knowledge and resources that will collective efforts to broaden the future therapeutic use of SC-based treatments for diabetes.